RNA-induced transcriptional gene silencing in Friedreich ataxia

DESCRIPTION (provided by applicant): Friedreich ataxia patients are homozygous for abnormally expanded GAA triplet-repeats in the first intron of the FXN gene. The expanded GAA triplet-repeat sequence results in a deficiency of FXN transcript which is reversed via administration of histone deacetylase inhibitors, indicating that transcriptional silencing is at least partly due to an epigenetic abnormality. Our preliminary data show that Friedreich ataxia patients have heterochromatin formation involving the critical +1 nucleosome of the FXN gene, thus offering a potential mechanism for the transcriptional silencing. We found that heterochromatin formation at the +1 nucleosome and the ensuing deficiency of FXN transcript are associated with overexpression of a novel antisense transcript, FAST1 (FXN Antisense Transcript 1), that overlaps with the +1 nucleosome, and higher levels of a novel, promoter-associated microRNA, miR-FXN1. Given that both antisense RNAs and microRNAs are able to induce heterochromatin formation, leading to transcriptional silencing in mammalian cells, we hypothesize that loss-of-function of the FXN gene in FRDA is caused by RNA-induced heterochromatin formation and transcriptional gene silencing. We will test this hypothesis by investigating the potential roles of FAST1 and miR-FXN1 in inducing heterochromatin formation and transcriptional gene silencing of the FXN gene in Friedreich ataxia. Furthermore, we will test if the epigenetic defect seen in fibroblast cell lines from patients is also detected in Friedreich ataxia neurons derived from differentiation of induced pluripotent stem cells. Implication of FAST1 and / or miR-FXN1 in the pathogenesis of Friedreich ataxia would make them rational therapeutic targets to permit specific reactivation of the FXN gene. Indeed, we will also test the feasibility of reactivation of the FXN gene in Friedreich ataxia via targeted repression of FAST1 and miR-FXN1. This proposal will enhance our understanding of the pathogenesis of Friedreich ataxia, the most common inherited ataxia, and will potentially have important implications for the development of a specific therapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Patients with Friedreich ataxia, the most common inherited ataxia, have expanded GAA repeat sequences in their FXN genes. Preliminary results indicate that this leads to altered packaging of the FXN genes, turning off gene expression, and causing a deficiency of the essential protein frataxin. Our experiments are designed to determine the precise mechanism of this altered packaging in Friedreich ataxia, and to decipher methods to reverse it and restore normal gene function. Project Narrative Patients with Friedreich ataxia, the most common inherited ataxia, have expanded GAA repeat sequences in their FXN genes. Preliminary results indicate that this leads to altered packaging of the FXN genes, turning off gene expression, and causing a deficiency of the essential protein frataxin. Our experiments are designed to determine the precise mechanism of this altered packaging in Friedreich ataxia, and to decipher methods to reverse it and restore normal gene function. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Friedreich ataxia (FRDA) patients are homozygous for abnormally expanded GAA triplet-repeats in the first intron of the FXN gene1. The expanded GAA triplet-repeat sequence results in a deficiency of FXN transcript via at least two mechanisms: deficient transcriptional elongation through an abnormal secondary structure adopted by the expanded repeat tract2,3, and epigenetic silencing4-7. The latter occurs via heterochromatin formation at the FXN locus, as has been noted in the vicinity of the expanded GAA triplet-repeat in intron 1. Indeed, histone deacetylase (HDAC) inhibitors, which reverse heterochromatin formation, resulted in partial reversal of the deficiency of FXN transcript4 and its downstream effects8, supporting the importance of epigenetic silencing in the pathogenesis of FRDA. It is not exactly clear how the FXN gene is silenced in FRDA since heterochromatin formation was not detected in the FXN gene promoter4-6. However, our preliminary data show that FRDA patients have strong heterochromatin formation in the 5' untranslated region of the FXN gene involving the critical +1 nucleosome, thus offering a potential mechanism for transcriptional silencing in FRDA. We found that heterochromatin formation involving the +1 nucleosome and the ensuing deficiency of FXN transcript are associated with depletion of CTCF, a known chromatin insulator9-11. Moreover, we detected overexpression of a novel antisense transcript, FAST1 (FXN Antisense Transcript 1), that overlaps with the +1 nucleosome, and higher levels of a microRNA, miR-FXN1, that overlaps with the transcription start site (TSS) of the FXN gene. Given that both antisense RNAs and miRNAs can induce heterochromatin formation leading to transcriptional inhibition in mammalian cells12-18, we hypothesize that loss-of-function of the FXN gene in FRDA is caused by RNA-induced heterochromatin formation and transcriptional gene silencing. This hypothesis will be tested in the following four specific aims: Aim 1: To test the role of FAST1 in mediating heterochromatin formation and FXN transcriptional gene silencing in FRDA. (A) Stable cell lines will be created to allow inducible overexpression of FAST1. The effect of FAST1 overexpression on induction of heterochromatin formation at the +1 nucleosome of the FXN gene will be determined by chromatin immunoprecipitation (ChIP). Transcriptional gene silencing of the FXN gene will be detected by assaying nascent FXN transcript levels via nuclear run-on assays. (B) FAST1 levels will be reduced in cells from FRDA patients to test for alleviation of FXN transcriptional deficiency and reversal of heterochromatin at the +1 nucleosome. "Gapmers", single-stranded antisense oligonucleotides with a central DNA sequence that can recruit RNase H, will be designed to allow targeted reduction of FAST1 levels. (C) Quantitative RT-PCR will be performed to determine if the level of FAST1 overexpression, like FXN deficiency, correlates with GAA triplet-repeat length in a panel of cell lines from FRDA patients and controls that contain a wide range GAA triplet-repeat alleles (9 - 1100 triplets). Aim 2: To test the role of a miRNA-induced mechanism for heterochromatin formation and FXN transcriptional gene silencing in FRDA. (A) A miRNA antagonist, designed to inhibit miR-FXN1, will be transfected in cells from FRDA patients to test for reversal of heterochromatin formation and alleviation of FXN transcriptional deficiency. A fluorescein-tagged miRNA will be used to facilitate FACS sorting of transfected cells, which will be analyzed for heterochromatin formation by ChIP, and for nascent FXN transcript via nuclear run-on assays. (B) The role of the miRNA pathway in mediating transcriptional gene silencing in FRDA will be tested via siRNA-induced knockdown of Dicer, Drosha, AGO1 and AGO2. ChIP assays will be used to test for enrichment of key mediators of heterochromatin formation in FRDA cells. (C) The role of miR-FXN1 in heterochromatin formation, and whether it arises from processing of the FXN-FAST1 duplex, will be investigated via overexpression of mutant FAST1 deleted for the miR-FXN1 sequence, and via transfection of "hairpin" constructs that express the FXN-FAST1 duplex. (D) Cell lines containing 9 - 1100 GAA triplet-repeat alleles will be tested by quantitative RT-PCR to determine if miR-FXN1 levels correlate with repeat length. Aim 3: To test the functional significance of heterochromatin formation at the +1 nucleosome in transcriptional silencing of the FXN gene. (A) The HDAC inhibitor, compound 106 (a pimelic diphenylamide), known to increase FXN levels via inhibition of HDAC3, will be used to test if it reverses the heterochromatin formation at the +1 nucleosome in FRDA cells. (B) miRNA-induced heterochromatin formation will be targeted to the +1 nucleosome (using an antigene miRNA or a miR-FXN1 mimic) in non-FRDA cells, and its ability to cause FXN transcriptional silencing will be evaluated. Aim 4: To test if the epigenetic defect is present in FRDA neurons. Human neurons, differentiated from induced pluripotent stem cells, generated via reprogramming of fibroblasts from an FRDA patient (and a non- FRDA control), will be (A) tested for elements of the FRDA-specific epigenetic defect seen in cultured fibroblasts: heterochromatin formation at nucleosome +1, overexpression of FAST1 and miR-FXN1. (B) HDAC inhibitors will be used to test for reversal of heterochromatin formation and FXN deficiency. (C) Targeted repression of FAST1 and miR-FXN1 will be performed to test for reversal of FXN transcriptional silencing.